A Human Gut-Liver Platform with Microbiome Interactions for In Vitro Toxicology

ABSTRACT
While rodents have provided valuable information on key aspects of the gut-liver axis, there are fundamental
species-specific differences in the gut-liver axis, such as the composition of the microbiome, differences in liver
xenobiotic metabolism, and progression of alcoholic and metabolic fatty liver disease. Therefore, human-
relevant in vitro models now play important roles in complementing in vivo animal studies for basic science
and for drug screening. While considerable progress has been made in the development of human models of
intestine and the liver using physiologically relevant primary cells, very little has been done in engineering an
integrated human gut-liver model using primary cells. We have utilized droplet microfluidics to fabricate highly
monodisperse extracellular matrix (ECM)-based 3D liver microtissues containing primary human hepatocytes
and liver sinusoidal endothelial cells that are rapidly generated and functionally outperform self-assembled
hepatic spheroids and hepatocytes within bulk gels for 4+ weeks; furthermore, the microtissues can be further
augmented with human hepatic stellate cells and Kupffer cells. We have also separately developed in vitro
human intestine models using primary cells, which can be engineered to maintain gradients of O2 across the
basal and luminal surfaces to recapitulate the stem cell and differentiated cell compartments of the crypt; can
produce mucus; and are amenable to the incorporation of microbiota in the luminal compartment. Here, we will
engineer in vitro human gut-liver models of increasing complexities, which will be used to elucidate how
intestine, liver, and microbiota interact to modulate reciprocal functions. In aim 1, we will elucidate reciprocal
functional changes in a human gut-liver model containing primary human colonocytes and liver cells, while in
aim 2 we will introduce mucus and microbiota in the intestinal model and elucidate reciprocal crosstalk upon
co-culture with human liver microtissues. This proposal will yield a first-of-its-kind scalable human gut-liver
model containing primary cells for in vitro applications, such as compound screening and disease modeling.

Public health relevance
PROJECT NARRATIVE The intestine and the liver are anatomically and physiologically connected, referred to as the gut-liver axis, which also plays a key role in the pathogenesis of several liver diseases. Here, scalable human gut-liver models containing primary cells will be developed for in vitro applications, such as compound screening and disease modeling, and be used to elucidate the effects of reciprocal tissue crosstalk on cell phenotype modulation.